Cancer Metabolism and Growth

CANCER METABOLISM AND GROWTH PROGRAM
PROJECT SUMMARY/ABSTRACT
The Cancer Metabolism and Growth (CMG) Program has the overall goal to determine how oncogenic
alterations regulate tumor cell metabolism, growth, proliferation, survival, and tumor-host interaction to facilitate
disease progression. The ultimate aim is to identify new approaches to improve cancer treatment through
innovative biochemical, molecular and biological research. In vivo approaches to address metabolic, physical
and immunologic functions in cancer and state-of-the-art measurement of cancer metabolism are signature
Program features that span the Rutgers/Princeton consortium. CMG provides the platform for productive,
collaborative, and impactful science, and interfaces with the Cancer Center for the translation of that science,
both bench to bedside and bedside to bench. CMG has 59 members from 26 Departments, 10 Schools, and
3 Universities. CMG research is well funded with $14.3M annual direct peer-reviewed grant support, $9.2M
of which is cancer-focused (9 multi-PI), with $3M from the NCI (21 R01-equivalent/14 PIs). In the last
funding period CMG members published more than 835 papers, 31% of which are collaborative (15% intra-
and 22% inter-collaborative) with 21% top-tier journals and 50% collaborative with other institutions. In
comparison to the last funding period, this represents an increase in both total and collaborative
publications, and seven additional multi-PI grants. Impactful CMG cancer science includes the
discovery that circulating lactate is a major supplier of carbon to the tricarboxylic acid (TCA) cycle in
tumors, and that the folate pathway significantly contributes to NADPH production. How glutamine
metabolism is critical for MYC-driven cancers, how mTOR signaling is controlled by nutrient availability, and
how protein and lipid scavenging contribute to cancer growth, proliferation and survival were also
discovered by CMG research. Examination of metabolic interactions between tumor and host revealed new
mechanisms of metastasis, and how tumors physically interact with their local environment and the immune
system. Program members discovered that metastasis represents corruption of normal developmental
processes, that cell polarity and tissue/cytoskeletal tension in the tumor microenvironment alter oncogenic
signaling via the Hippo and other pathways, and that nutrient scavenging, interferons and the removal of dead
cells by efferocytosis alter the immune response to tumors. Translation of CMG research has led to clinical
trials targeting metabolism, promoting apoptosis and activating anti-tumor immune responses. In turn, clinical
observations have informed CMG research to model treatment, resistance and exceptional responders to
identify underlying mechanisms and to improve therapy.